Rapid, Multiplexed Point-Of-Care Molecular Detection of Respiratory Pathogens without Sample Prep

Rapid, Multiplexed Point-Of-Care Molecular Detection of Respiratory Pathogens without Sample prep CrossLife Technologies, Inc. & University of Washington RESEARCH & RELATED Other Project Information 7. Project Summary Respiratory infections are one of the most common reasons for doctor visits and the most common illness resulting in missed work or school. Respiratory infections are caused by viruses or bacteria. Acute respiratory infections such as pneumonia, flu, and respiratory syncytial virus are responsible for 4.25 million deaths worldwide each year [1-2]. Acute respiratory infections are world’s third leading cause of death worldwide mostly in the developing world where resources are limited, and labs or expensive instruments in labs are not available [3]. Rapid low-cost tests for pathogens that cause respiratory infections are needed for situations where a lab or transport to a lab is not available, especially in the resource limited settings of the developing world where the burden of acute respiratory infections is the highest. We aim to develop a rapid point-of-test that detects 21 respiratory pathogens (viruses and bacteria) and is appropriate for non-laboratory settings and non-technical personnel. Our proprietary test exploits a novel probe reaction chemistry that allows multiplexed detection of DNA or RNA without sample purification, making it operable as a simple, hand- held test. Patient samples to be input directly into the device without pre-processing and a disposable cartridge carries out amplification of all targets and reports visual results that can be read by eye or a low-cost imager. The key goals of the project are to 1) develop a prototype device that can detect up to 21 respiratory pathogens and to 2) validate it using clinical samples. Availability of rapid-turnaround respiratory pathogen testing will allow infected patients to be isolated with infection control and/or treated in real time without loss to follow up, which could avoid costs for hospital stays ($2,000 a day), enable better outcome, and contribute reduced antibiotic resistance. Finally, the TARAPlex test will be less expensive ($100 in the U.S.) than BioFire multiplexed PCR ($1,200 per test).

Public health relevance
Rapid, Multiplexed Point-Of-Care Molecular Detection of Respiratory Pathogens without Sample prep CrossLife Technologies, Inc. & University of Washington RESEARCH & RELATED Other Project Information 8. Narrative Respiratory infections are one of the most common reasons for doctor visits and the most common illness resulting in missed work or school, and they are world’s third leading cause of death worldwide. We will develop a rapid low-cost test for respiratory infections that can be used for rapid diagnosis in the US medical facilities or low-resource settings globally.